Mechanisms of maternal Immunoglobulin A control over the neonatal microbiota and the development of Necrotizing Enterocolitis

ABSTRACT In infants the microbiota develops along a standard trajectory, where early colonization with
facultative anaerobes (Enterobacteriaceae) transitions to dominance by Bifidobacteria until children begin to
consume solid food. Deviations in the trajectory of intestinal bacterial colonization are associated with disease.
In particular, preterm infants are dominated by Enterobacteriaceae for much longer than term infants, and
these bacteria can invade the preterm intestinal epithelium, contributing to the of development of Necrotizing
Enterocolitis (NEC). NEC is a devastating disease that is still lethal to ¼ of infants that develop it and leads to
long term complications for many others. Breast milk contains bioactive molecules that directly modulate infant
bacterial colonization, including antibodies, such as Immunoglobulin A (IgA). IgA is the predominant antibody
found in breast milk and is secreted into milk by B cells that travel to the mammary gland from the mother’s
intestine. In preterm infants, IgA binding to Enterobacteriaceae is inversely correlated to the development of
NEC. We have demonstrated that the anti-bacterial reactivity of milk-derived IgA varies significantly between
individuals and that a lack of IgA binding to intestinal bacteria in neonates leads to significantly increased
intestinal Enterobacteriaceae, immune cell activation and accumulation. However, how IgA shapes
host/bacteria and bacteria/bacteria interactions that define the assembly of the neonatal microbiota remains
poorly understood. Our hypothesis is that maternal IgA, provided in breast milk, regulates the composition and
transcriptome of neonatal intestinal bacteria, the activation of immune cells and the development of NEC.
Using both samples collected from preterm infants and gnotobiotic mice carrying a defined bacterial
consortium we will test this hypothesis. To identify how IgA shapes the absolute abundance of various
members of the microbiota, we developed (Microbiota Flow Cytometry; MicFLY) a method that provides
accurate single cell resolution of bacteria at all taxonomic levels. MicFLY can also be used to sort bacteria prior
to RNAseq (MicFLYseq). Here, in three aims, we propose to use MicFLY and MicFLYseq to determine how
milk-derived IgA shapes the development of the neonatal microbiota and NEC. In Aim 1, using a cohort of daily
collected infant fecal samples we will define how feeding modality and IgA binding shape the formation of the
preterm microbiota and NEC. In Aim 2 we will determine how IgA binding shapes intestinal bacterial
transcription to modulate immune-driven inflammation and the development of NEC. In Aim 3 we will use
gnotobiotic mice to test whether infant bacterial colonization is shaped by the anti-bacterial reactivity of
maternal intestinal IgA. Together this proposal will define the assembly of the infant microbiota at the single cell
level, determine the role of IgA in modulating intestinal bacterial transcription and colonization and identify how
IgA control of the microbiota reduces the incidence of NEC. Our proposal has the potential to uncover how
milk-derived IgA could be used to improve infant health and reduce the incidence of NEC.

Public health relevance
Project Narrative Necrotizing Enterocolitis (NEC) is a devastating disease of preterm infants that can result in lifelong disability and death. The development of NEC is not fully understood but is related to the invasion of the infant intestine by the nascent microbiota. Here we propose to use novel single cell techniques to understand how breast milk- derived antibodies shape the maturation of the preterm intestinal microbiota and the development of NEC.